Central Processing of Visual Information

This project consists of a set of inter-related experimental, computational, and theoretical studies,
whose goal is to advance the understanding of the design principles of visual processing, and how these
design principles are reduced to computations that can be carried out by neurons and neural circuitry. The
many successes of “normative theories” constitute our starting point: for example, how a sensory system's
limited capacity should be deployed to effectively represent and transmit task-relevant information about its
inputs. However, here we recognize that along with these successes – in our lab and many others -- there are
many divergences between normative predictions and what the visual system actually does. These
discrepancies indicate that there are important constraints not recognized by current normative theories, such
as limits to the detail with which natural-image priors are used.
We focus on the extraction of figure from ground: this is a computationally-challenging process that is
centrally important to visual function, and it also has a number of characteristics that we can use to advantage,
building on recent advances in our lab. Distinguishing figure from ground is a fundamentally statistical
process, so understanding how the visual system processes local image statistics is critical. In previous years,
we developed a theoretical and experimental framework for this: we showed how luminance, contrast,
orientation, and shape could be dissociated via the construction of a space of synthetic textures, and we then
used this space to measure human visual sensitivity to these components individually and in combination and
to analyze its relationship with natural-image statistics.
Aim 1 consists of psychophysical experiments to characterize three key aspects of figure-ground
processing: Aim 1A, the influence of the statistics of figure, ground, and figure-ground differences, Aim 1B, the
influence of figure shape, and Aim 1C, the influence of task-specific knowledge. Aim 2 is motivated by models
that formalize the hypothesis that visual computations make use of simplified Gaussian approximations to
natural image statistics. To test these models, Aim 2A consists of computational studies to determine the
statistics of image patches in figure and ground. Aim 2B makes further psychophysical measures that will
determine a phenomenological model. Comparison of the phenomenological model and normative models
built from natural-image statistics will proceed in stages: does the phenomenological model have the form
predicted by normative theories (i.e., do measured threshold surfaces have the predicted shape)?I f so, what is
the level of detail of natural-image priors that are needed to account, quantitatively, for perceptual thresholds?
Successful completion of this research is expected to provide both specific and generalizable insights
into principles of sensory processing, which in turn will provide the groundwork for advanced neural prosthetics
and assistive devices.

Public health relevance
Project Narrative (Public Health Relevance) To guide action and support perception, visual information from the retina must be interpreted by neural computations carried out in the brain. The proposed research aims to advance the understanding of this process, with a focus on how the brain reduces potentially intractable computational problems into algorithms that can be carried out with neural hardware. Successful completion of this research will provide infrastructure for the rational design of advanced neural prosthetics for patients with visual loss, and of machine vision algorithms that have the potential to improve medical diagnosis and provide more effective assistive devices.